AIDS STUDY--ANTI-PCP AGENTS AND ZIDOVUDINE IN ADVANCED HIV INFECTIONS

To compare the 24-month efficacy and tolerance of 3 combinations of Zidovudine and an anti-infective agent in patients with advanced HIV disease.